Training Component

PROJECT SUMMARY
The overall goal of the MARCH Training Component is to enhance knowledge and skills for investigators and community
partners to conduct research and improve care for pregnant women to reduce the risk of pregnancy-associated
mortality and morbidity in rural and American Indian communities. The training component activities align with the
thematic focus of MARCH – improving access and accessibility of care and enhancing the understanding of key barriers
and facilitators for change. To that end, the training activities will engage and support community partners and MARCH
investigators by enhancing knowledge about the influence of the sociocultural, economic, and regulatory landscape on
healthcare access for rural pregnant and postnatal women. The training component will provide training on two broad
overarching areas that apply across all research projects and community partners - enhancing efforts to improve cultural
competency and research literacy for investigators and community partners. Additionally, training to enhance
knowledge and skills related to specific project areas will be provided. The provision of continued professional
development is an important component of training activities for research staff. Finally, the training component will
focus on creating a pipeline of researchers committed to a research career in maternal health through structured
mentorship, skill development, and community engagement experiences derived from long-standing community
partnerships. Building community relationships can take a long time. MARCH will allow early-stage investigators and
students to use this platform to springboard their own relationships and research programs.